Optimizing medication use and support among people with dementia who live alone

PROJECT SUMMARY/ABSTRACT
Unchanged from K76AG088411

Public health relevance
PROJECT NARRATIVE Unchanged from K76AG088411